Brain and eye pressure-induced optic nerve and retinal degeneration

Project Summary
Glaucoma represents a number of complex diseases with a common endpoint of retinal ganglion cell (RGC)
and optic nerve degeneration. Two major models of glaucoma pathogenesis exist – the mechanical
hypothesis, which is based on the interaction of intraocular pressure (IOP) and intracranial pressure (ICP), and
the vascular hypothesis, which is based on factors that reduce blood flow to RGCs and the optic nerve.
Preliminary results from our laboratory suggest that experimental manipulations of mechanical factors such as
IOP and ICP in mice result in a range of microvascular and hypoxic abnormalities in the retina. These
abnormalities appear to differ not only according IOP and ICP level and exposure duration, but among retinal
cell types. In particular, we are interested in RGCs and amacrine cells (ACs), which are critical upstream
regulators of RGC function. In this renewal application, we propose to identify the earliest differential
responses of RGCs, ACs, and the retinal vasculature to IOP and ICP variation, and to determine the impact of
the hypoxic mechanisms that underlie these responses. There are three specific aims: (1) determine the
mechanism and differential susceptibilities of retinal capillary plexi to changes in IOP and/or ICP; 2) delineate
the differential hypoxic responses that occur in RGCs and ACs after changes in IOP, and test the hypothesis
that hypoxia in ACs causes physiologic dysfunction in RGCs; and 3) to test the hypothesis that HIF1, the
primary regulator of the hypoxic response, is required for ICP-induced RGC injury. Throughout these Aims, we
will employ novel experimental tools that enable us to elevate IOP and ICP to predictable levels for specific
durations, which allow us to assess the effects of both magnitude and duration of IOP/ICP change. We will
also use a new technique to isolate and culture adult RGCs and AC with high fidelity to probe the differential
responses of both cell types to hypoxia and preceding IOP injury. Used in conjunction with a series of in vivo
and post mortem electrophysiologic, behavioral, anatomic, and transcriptomic assessments of RGCs, ACs,
and the retinal vasculature in both wild type and transgenic mice, we will determine the relative contributions of
IOP and ICP change, and assess how alteration of hypoxia and the hypoxic response modifies these
contributions to impact RGC/AC dysfunction and survival. Our research will provide an important link between
mechanical and vascular hypotheses of glaucoma pathogenesis, potentially identifying a unified theory for
susceptibility to glaucoma that can guide future translational diagnostic and therapeutic studies.

Public health relevance
Project Narrative Glaucoma is a progressive neurodegenerative disorder of the optic nerve and retina and affects a substantial percentage of the adult and elderly population of the United States. Mechanical models of glaucoma pathogenesis center on the effects of intraocular and intracranial pressure, whereas vascular models focus on reduced blood flow and oxygen delivery. In this proposal, we will integrate these models and determine how modification of mechanical factors in mice disrupts retinal vascular biology and the hypoxic response, and how this causes glaucomatous injury.